Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT: Biostatistics and Bioinformatics Core
The Biostatistics and Bioinformatics Core (B&B Core) is a cornerstone of the Harvard University Center for AIDS Research (HU CFAR), consistently identified as one of the most important sources of value added. The objectives of the B&B Core are closely linked to the overall CFAR mission: catalyze HIV research and enhance the careers of Harvard-affiliated HIV investigators, with a particular emphasis on Early Career Investigators (ECIs) by providing biostatistics and bioinformatics expertise for the planning, design, conduct, analysis, and reporting of HIV research (including laboratory, animal, clinical, behavioral, prevention, outcomes, and implementation studies); assist in preparing grant proposals; offer mentorship; and educate users in quantitative methods.